Airway epithelial cell and lymphocyte interactions in chronic lung allograft dysfunction pathogenesis

Project Summary/Abstract
The major barrier to long term survival following lung transplantation is a progressive loss of lung function, termed
chronic lung allograft dysfunction (CLAD), for which constrictive fibrosis in small airways is a pathologic hallmark.
CLAD affects over half of lung transplant recipients by 4 years post-transplant and negates much of the quality
of life and functional improvements associated with transplantation. Pitt, Toronto, and UCSF lung transplant
programs have refined transcriptional analysis of small airway brushings from lung transplant recipients as a
novel technique to understand the gene expression changes at the anatomical site where CLAD pathology is
developing. We have published gene expression changes associated with CLAD validated across our centers.
This proposal will leverage this innovative approach to understand the mechanisms of CLAD pathogenesis. Our
preliminary data show an early upregulation of hypoxia pathways in airway brushings including genes that recruit
and activate cytotoxic lymphocytes using both airway epithelial cell culture in hypoxic conditions and pathway
analysis of airway brush transcriptomes. This hypoxia signaling may reflect disordered microvasculature, absent
bronchial circulation, and vascular inflammation associated with lung transplant. We also observed upregulation
of tumor necrosis factor superfamily (TNFSF) co-stimulatory molecules that may drive alloimmune responses.
Finally, our data show apoptosis in airway club cells, the protectors and progenitors of small airways, in
association with TNF-related apoptosis-inducing ligand (TRAIL). Single cell investigations in airways and
bronchoalveolar lavage (BAL) fluid show the segregation of these pathways across epithelial and lymphoid cell
types. Based on these data, we hypothesize that airway hypoxia leads to TNFSF-mediated T cell activation and
subsequent apoptosis of airway club cells that drive CLAD pathogenesis. To test this hypothesis, we will generate
parallel cohorts investigating bulk and single cell transcriptomes of CLAD versus controls across three centers,
allowing for rigorous cross validation of gene expression signatures. We will complement these studies with cell
culture-based methods to determine mechanisms driving these gene expression changes. In Aim 1, we will
determine the airway-specific gene signature of hypoxia and test whether this precedes CLAD. In Aim 2, we will
determine the cellular sources and kinetics of TNFSF co-stimulatory molecule expression in CLAD using airway
brushes and BAL fluid. Then in Aim 3, we will examine whether TRAIL preferentially induces club cell apoptosis.
The synergy of three large lung-transplant translational research programs with world-class cross-institutional
biostatistical infrastructures provides a unique opportunity to address this hypothesis with rigor. The gene
expression signatures defined by cell type and time course of CLAD that will be developed through this study
are critically needed as surrogate biomarkers to support clinical trials of targeted therapies and to pioneer a novel
approach to CLAD diagnosis.

Public health relevance
Project Narrative While lung transplantation promises improvements in survival, function, and quality of life for some end-stage lung diseases, survival after transplantation is limited by scarring in small airways. This proposal will leverage brushes of the small airways as a novel tool to understand how the abnormal blood supply to the transplanted lungs could lead to inflammation and destruction of airway progenitor cells. Success in this project will improve diagnosis of lung graft scarring and allow for development of treatment approaches to prevent or reverse this disease.